Longitudinal study of sleep duration, reward and cognitive control circuits, and vulnerability for depression and suicidal ideation during adolescence

Project Summary
Adolescence begins a period of vulnerability for depression and suicidality, as well as for sleep loss. Short sleep
duration is extremely common in youth (i.e., 44% of high school students report 6 or less hours of sleep on
school nights), and is a risk factor for depression, suicidality, and other negative outcomes. Sleep loss is
hypothesized to exert an influence on internalizing symptoms by disrupting reward and cognitive control neural
pathways. These brain networks continue to develop during adolescence, are implicated in the development and
maintenance of depression, and have been shown to be sensitive to acute sleep restriction in our prior
experimental work. Our findings of blunted activation within both reward and cognitive control circuitry following
sleep restriction (as compared to sleep extension) provide plausible mechanisms by which sleep loss is involved
in the pathway to developing internalizing psychopathology. The next critical step to extend this line of work is to
examine the cumulative effects of insufficient sleep, to examine sleep-brain relationships naturalistically during
the school year, and to examine the extent to which these predict longitudinal changes in depression and
suicidality. These are the goals of our proposed study. We propose to enroll a sample of 210 youth ages 11.5–
14.5 (66% female), who are currently in the 7th, 8th, or 9th grades, representing a continuum of habitual sleep
duration, but ensuring 50% with 7 or fewer hours of sleep. Participants will then be followed for the next 4 years
during the peak risk for depression onset during adolescence, with annual assessments of sleep via actigraphy
and behavioral measures (reward learning, cognitive control), along with fMRI scans at baseline (7th–9th grade)
and repeated 2 years later (in 9th–11th grade). Self-report internet-based assessments will be collected quarterly
(every 3 months; 14–16 in total) to examine more nuanced temporal associations between changes in sleep
duration, depression symptoms, and suicidal ideation. In this longitudinal 4-year design, we will examine how
declining sleep duration influences reward and cognitive control, and whether sleep and these mechanisms
jointly predict subsequent depression symptoms and suicidal ideation. Insufficient sleep may be an important—
yet modifiable—vulnerability factor for psychopathology. Understanding the temporal associations linking sleep
and mental health—as well as the role of neural mechanisms—will help better target sleep-focused interventions
by determining when, and in whom, they would best be directed. Study findings will provide leverage for
developing novel interventions, augmenting existing (sleep or mental health) treatments, and/or changing public
policy (i.e., later school start times) to improve adolescent sleep, and ultimately, prevent internalizing disorders.

Public health relevance
Project Narrative Sleep loss is extremely common and worsens across adolescence precisely when rates of depression are peaking. We will study how neural responses to reward and cognitive control are associated with sleep duration over a four-year period, and how vulnerability to sleep loss predicts increased depressive symptoms and suicidal ideation. Because sleep is a modifiable risk factor, we hope that this work will lead to novel interventions or augmentation of existing treatments, identifying when and in whom to intervene, as well as providing leverage for public policy change, such as the adoption of later school start times for middle and high school students, in service of preventing problems like depression and suicide during adolescence.